The Philadelphia Program for Mentored Research Training in Kidney, Urologic, and Hematologic Diseases (PERFORM-KUH U2C/Tl1)

Project Summary/Abstract
Expanding a talented research workforce focused on kidney, benign genitourinary tract, and benign
hematological diseases, trained in critical scientific approach, in emerging concepts, and in advanced
experimental approaches is fundamental to addressing the personal and socio-economic burdens associated
with these diseases. Toward this end, we will create a comprehensive training program that encompasses
research training in science related to nephrology, urology, and hematology across the lifespan entitled the
Philadelphia Program for Mentored Research Training in Kidney, Urologic, and Hematologic Diseases
(PERFORM-KUH). Centered in Philadelphia, PERFORM-KUH will: #1 Build/enhance a biomedical research
training program that integrates remarkably successful, well-established, already collaborative training programs
at the University of Pennsylvania (Penn) and the Children’s Hospital of Philadelphia (CHOP), and pre- and post-
doctoral programs at Temple, Jefferson, and Drexel Universities. #2 Prepare PhD, MD, or MD/PhD pre- and
post-doctoral students from all PERFORM-KUH participating organizations for careers as successful
investigators working in areas related to KUH in settings that include academia, research institutes, and industry.
We will (a) provide training in state-of-the-art experimental approaches in bench, translational or clinical research
settings relevant to disease of the kidney, genitourinary tract, and hematology across the lifespan (limited to
areas relevant to the KUH section of NIDDK); (b) offer a formally structured and carefully monitored mentoring
process; (c) create enrichment programs that foster professional development; and (d) enable peer-peer and
peer-near peer networking between our trainees and recent graduates. #3 Stimulate interest in research relevant
to kidney, urologic, or hematologic diseases with the goal of enriching the pipeline of scientists dedicated to
these areas. While doing so, we will recruit, include, and foster opportunity for those underrepresented in
medicine. #4 Maintain programs for “mentoring the mentor” that provides training in mentoring with meaningful,
continuous evaluation and feedback to mentors and that teaches mentoring skills to junior faculty. #5 Establish
and manage a well-organized and properly staffed administrative core that ensures governance, collaboration,
and communication within the new training program, and provides for ongoing evaluation and continuous
improvement. PERFORM-KUH will provide an exceptional environment for training in state-of-the-art scientific
principles and methodology, that encourages creativity, that guides professional development, and that provides
mentoring and sponsorship.

Public health relevance
Training a talented research workforce focused on kidney, benign genitourinary tract, and benign hematological diseases is fundamental to addressing the personal and socio-economic burdens associated with these diseases. Toward this end, we will create a comprehensive training program in Philadelphia that encompasses research training in science related to nephrology, urology, and hematology across the lifespan entitled the Philadelphia Program for Mentored Research Training in Kidney, Urologic, and Hematologic Diseases (PERFORM-KUH).